Administrative Core

PROJECT SUMMARY ADMINISTRATIVE CORE
The Center for Systems Neurogenetics of Addiction (CSNA) merges advanced experimental and computational
approaches in sophisticated mouse model systems with experts in behavioral neuroscience, computational
biology and genetics, to interrogate the overlapping biological factors underlying risk for psychostimulant
addiction. The CSNA draws on the experience and expertise of three highly accomplished researchers based
at The Jackson Laboratory (JAX); SUNY–Binghamton University; and the University of North Carolina Chapel
Hill. By integrating these programs through resource sharing, experimental and analytical standardization,
and collaboration, the CSNA will enable a synergistic, multi-dimensional analysis of risk for psychostimulant
abuse, while sharing data, resources and expertise with the research community. To fully capitalize on the
extensive knowledge base afforded by this geographically dispersed team, and to efficiently synthesize and
disseminate novel methods, findings and educational opportunities, the CSNA will be guided by a strong,
centralized and well-organized Administrative Core (Admin Core). The overall objectives of the Admin Core
are: 1) Communication. The Admin Core will organize and oversee regular scientific meetings to foster
communication and synergy within and across the projects and cores of the CSNA, and to nurture a strong,
collaborative environment across all sites, including those external to JAX. Regular communication between
Admin Core leadership, the Internal Executive Committee (IEC) composed of the PI and all Core and Project
Leads, and an External Advisory Board (EAB) composed of experts in the field, will optimize both progress of
the CSNA towards its goals and stewardship of the Center as a resource of national impact. 2)
Oversight/Management. The Admin Core will provide scientific and administrative oversight of CSNA
research projects, cores and pilot programs. This oversight will include assessment and decision-making,
project management,
timely preparation of reports, regular fiscal review, intellectual property management,
regulatory compliance, involvement of institutional and programmatic resources, pilot project review, and
regular review of research and publication progress. As part of its oversight and program review, the EAB will
provide critical perspectives on CSNA progress, make recommendations on overall scientific direction, and
provide guidance on logistic, scientific and fiscal challenges faced by the Center. The Admin Core, together
with the IEC, are responsible for implementation of EAB recommendations. 3) Education, Outreach and Career
Development. The Admin Core will provide outreach to further public awareness of addiction research and of
the CSNA and enhance professional training, education and career development in the genetics of addiction for
a diversified addiction research workforce. This will be accomplished through a suite of offerings that leverage
the well-established resources available at JAX for education and outreach.